Mindfulness Intervention for Sleep Disturbance and Symptom Management in Hematologic Cancer Patients During and After Inpatient Treatment

Patients with life-threatening hematologic cancer experience insomnia and fatigue, distress, and pain symptoms
that worsen insomnia during and following hospitalization for high-dose chemotherapy. Despite an urgent need,
there are limited symptom management protocols that comprehensively target the challenging treatment (i.e.,
inpatient, outpatient) and symptom demands faced by hematologic cancer patients. We developed and tested a
6-session, therapist-led, telehealth intervention for hematologic cancer patients following discharge from
inpatient treatment (Nite2Day). Nite2Day teaches mindfulness meditations and behavioral strategies to improve
insomnia and related fatigue, distress, and pain symptoms. Nite2Day demonstrated strong feasibility,
acceptability, and significant improvements to primary (insomnia; d=1.20) and secondary outcomes (fatigue,
distress, mindfulness; ds=.38-.89). Nite2Day does not address the inpatient setting where patients describe
sleep quality as especially poor. This pilot randomized controlled trial will extend Nite2Day to the inpatient setting
(Nite2Day+) and assess its feasibility, acceptability, engagement, and outcome patterns. Hematologic cancer
patients (N=60) reporting insomnia symptoms during hospitalization will be randomized (1:1) to Nite2Day+ or
Usual Care. Nite2Day+ will be delivered via a self-paced mobile app in the hospital and include: 1) mindfulness
meditations promoting acceptance of the challenging inpatient setting; 2) brief videos on sleep education (e.g.,
sleep drive, circadian rhythm) and behavioral strategies to improve inpatient sleep quality (e.g., stimulus control,
daytime activity); and 3) tools to manage inpatient sleep disruptions (e.g., sleep mask, ear plugs). Once
discharged home, patients will transition to the previously tested, 6-session protocol. We hypothesize that: 1)
Nite2Day+ will be feasible (accrual N=60/24 months; <25% attrition; >75% adherence to assessments and
intervention), acceptable (M>3/5 satisfaction with procedures; M>3/4 satisfaction with Nite2Day+), and engaging
(Nite2Day+ app log-in, video/skills practice >2x/week); and 2) Nite2Day+ will improve insomnia symptom severity
(primary outcome) and secondary outcomes (fatigue, distress, pain, pre-sleep arousal, mindfulness, symptom
management self-efficacy) from baseline to hospital discharge and after the 6-session protocol, compared to
Usual Care. Dr. Fisher will receive advanced training and expert mentorship in behavioral sleep and cancer
symptom management and behavioral intervention development for inpatient and outpatient settings, and
randomized trial designs and statistical methods for optimizing behavioral treatment regimens to improve the
transition from inpatient to outpatient settings. This training will help Dr. Fisher pursue a future sequential multiple
assignment randomized trial assessing insomnia and symptom management strategies that are responsive to
challenging treatment (i.e., inpatient, outpatient) and heterogeneous symptom demands faced by hematologic
cancer patients. Findings could inform adaptation of other psychosocial interventions for the inpatient setting,
and establish a new model of systematic symptom management for various cancer and hospitalized populations.

Public health relevance
PROJECT NARRATIVE Insomnia and related symptoms (e.g., fatigue, distress, pain) that worsen insomnia are common, distressing, and persistent for patients in the hospital receiving high-dose chemotherapy for life-threatening hematologic cancer. Insomnia and symptom management during and following intensive inpatient treatment is urgently needed for this high-risk cancer population and represents a key NIH/NCI initiative; yet, this is a neglected area of research as there are limited insomnia and symptom management protocols that comprehensively address the challenging treatment course (i.e., inpatient, outpatient) and symptom demands (e.g., insomnia, fatigue, distress, pain) faced by hematologic cancer patients. A pilot randomized controlled trial will assess the feasibility, acceptability, engagement, and outcome patterns of a mindfulness-based insomnia and symptom management intervention bridging inpatient and outpatient settings to improve cancer morbidity in a vulnerable yet understudied cancer population.